"SELF" DIRECTED STRATEGIES FOR WEIGHT LOSS AND MAINTENANCE

The purpose of this study is to determine the influence of emotional states, self esteem, and self efficacy on weight loss and its long-term maintenance.